COMPARISON OF BID VS QD DOSE REGIMEN OF HOE490 (GLIMEPIRIDE)

This is part of multicenter study comparing BID vs QD dose regimen of the oral hypoglycemic sulfonylurea agent HOE 490 (glimepiride) in subjects with non-insulin dependent diabetes mellitus who have previously received other sulfonyl-urea agents.